ORAL ALENDRONATE SODIUM--PREVENTION/TREATMENT OF GLUCOCORTICOID INDUCED BONE LOSS

The purpose of this study is to evaluate Alendronate Sodium for the prevention and treatment of glucocorticoid-induced bone loss. Bone mineral density in lumbar vertebrae will be analyzed by dual energy x-ray absorptiometry (DEXA).